Mitochondrial Zn2+ in ischemic neurodegeneration: In vivo tests of principle studies in a rat cardiac arrest model

Project Summary/Abstract Therapy for ischemic brain injury is poor in part because of our limited understanding of mechanisms leading to neuronal loss. While contributions of excessive glutamate release and neuronal Ca2+ accumulation have been much studied, recent evidence implicates critical contributions of another divalent cation, Zn2+. After ischemia or prolonged seizures, free Zn2+ accumulates in neurons, and observations that Zn2+ chelation is protective implicates a role in neuronal death. Culture studies have revealed that exogenously applied Zn2+ can enter neurons and accumulate in mitochondria, powerfully disrupting their function. However, little is known about mechanisms of injury caused by the accumulation of endogenous Zn2+ in native brain tissues. Using acute hippocampal slices subjected to oxygen glucose deprivation (OGD) to model ischemia, we recently made the first simultaneous measurements of cytosolic Zn2+ and Ca2+ changes, and found that Zn2+ accumulation is an early event in hippocampal pyramidal neurons, that precedes and contributes to subsequent cell death. These acute deleterious effects of Zn2+ appear to result specifically from Zn2+ uptake into mitochondria via the mitochondrial Ca2+ uniporter (MCU). The proposed studies are organized around a Hypothesis: Zn2+ contributes to the early stages of ischemic neuronal injury, in part via entering and inducing acute disruption of mitochondrial function. The primary goal of this study is to make an early assessment of this hypothesis in vivo, using of an established model of global cerebral ischemia resulting from asphyxial cardiac arrest. Aim I will use the cardiac arrest model to characterize Zn2+ and mitochondrial dependent changes and neuronal injury in different brain regions, as a function of both the duration of ischemia and the duration of recovery prior to assessment. Aim II will test a number of interventions targeting acute and subacute effects of Ca2+ and Zn2+, administered either alone or in combinations as suggested by our hippocampal slice studies, that we predict will abrogate certain shortcomings of the individual interventions. They will be delivered either before ischemia, or only upon reperfusion to assess potential for benefit with delayed administration. These studies will provide a bridge between compelling mechanistic clues derived from in vitro studies and efforts to forge better therapies for degeneration after in vivo ischemia, and we hope that they will lead to the elucidation of new types of interventions, to be delivered either during the acute phase of ischemia or upon reperfusion, that will disrupt the pathological cascade, enabling improved outcomes.

Public health relevance
8. Project narrative Although stroke is a cause of tremendous morbidity to the aging population, treatment is presently poor in part because of limited understanding of the events set in motion by ischemia that culminate in loss of function and nerve cell death. Despite strong evidence that excitotoxicity and neuronal Zn2+ accumulation both contribute to degeneration after ischemia, therapeutic interventions targeting these mechanisms have been disappointing. We have used culture and slice models to study relevant mechanisms of endogenous Zn2+ and its interactions with Ca2+ in the induction of ischemic injury. We now propose to carry out early in vivo test-of- principle studies - informed in part by insights gained from our studies in hippocampal slice - to examine some interventions that we hope will abrogate deficiencies of prior therapeutic strategies yielding improvements in neuroprotective efficacy, and be effective when delivered either during ischemia or more significantly from a therapeutic standpoint, in the reperfusion period after restoration of blood flow. We hope that the studies will ultimately lead to new and effective approaches to decrease brain damage after transient ischemia.